Tissue transglutaminase as a therapeutic target for arterial stiffening and hypertension in obesity

PROJECT SUMMARY/ABSTRACT
Arterial stiffening and microvascular inward remodeling are early and independent predictive risk factors of
cardiovascular disease (CVD) and mortality. In obesity, these risk factors occur early, preceding and
contributing to the development of hypertension and organ dysfunction. However, despite CVD being the
primary cause of mortality in individuals with obesity, no treatments are currently available for obesity-
associated vascular stiffening and remodeling. This is due, in part, to an unclear understanding of the
underlying mechanisms for these common conditions. Rigorous published research and preliminary studies
indicate that vascular smooth muscle cell (SMC) tissue transglutaminase (TG2) is increased in obesity and that
TG2 activity contributes to arterial stiffening and microvascular inward remodeling. However, the mechanisms
by which obesity increases TG2 activity, how TG2 promotes arterial remodeling and contributes to
hypertension development, and whether TG2 could be targeted therapeutically to reduce CVD in obese
patients remain unclear. This proposal addresses those significant gaps in knowledge. The central hypothesis
of this proposal is that obesity-associated SMC TG2 upregulation and mechanosensation increase arterial
collagen crosslinking, actin polymerization, and myogenic tone, contributing to vascular stiffening and
hypertension. A corollary to this hypothesis is that treatment with the novel TG2-specific inhibitor, ZED3641,
will attenuate arterial stiffening and blood pressure in obese-hypertensive pigs. This innovative hypothesis will
be tested with gain- and loss-of-function genetic manipulation and pharmacological experiments in cultured
vascular SMC and isolated arteries, in animal models of SMC-specific MR and TG2 deletion, and in obese-
hypertensive pigs. Specifically, studies in Aim 1 will determine the mechanism of SMC mineralocorticoid-
dependent regulation of TG2 in obesity. In Aim 2, the role of TG2 mechanosensation in arterial stiffening,
myogenic vasoconstriction, and remodeling in obesity will be determined. Finally, studies in Aim 3 will
determine the arterial de-stiffening effects of TG2 inhibition in isolated arteries from obese patients and in a
swine model of obesity and hypertension. It is posited that targeting TG2 activity holds extraordinary promise
for correcting arterial stiffening, remodeling, and hypertension in obese patients, thus reducing their CVD
burden.

Public health relevance
PROJECT NARRATIVE Despite the importance of increased arterial stiffness in obesity-associated hypertension, there are currently no therapeutic drugs available that specifically target arterial stiffness to reduce the incidence of cardiovascular disease. This project will contribute to our better understanding of molecular mechanisms underlying obesity- associated arterial stiffening, remodeling, and hypertension. Specifically, this project will examine the novel hypothesis that inhibition of tissue transglutaminase activity can be used as a therapeutic strategy to correct arterial stiffening, remodeling, and hypertension in obesity.